THE GUT MICROBIOME IN DEVELOPMENT, HEALTH, AND DISEASE

[unreadable] DESCRIPTION (provided by applicant): People contain at least ten-fold more microbial than human cells. Recent data compel serious consideration of co-evolved microbial-host partnerships. We are, in fact, super-organisms and composites of many species. This nascent field of study has tremendous implications for human development, health, homeostasis, and disease, and the human enteric biomass represents the largest fraction of these organisms. For these reasons, we will present a course on the human intestinal microbiome in development, health and disease, in conjunction with the North American Society for Pediatric Gastroenterology Hepatology and Nutrition. The course will be open to a wide community of investigators in pediatrics, internal medicine, immunology, microbiology, dentistry, dermatology, and other fields, and feature lectures from a panel of pioneers in this discipline. Topics to be covered include the role of the intestinal microbiota in intestinal and extraintestinal inflammation, immune regulation, and the biology of probiotics. There will be particular emphasis on trainees, and preparation for careers in this multifacetted field. Biologic concepts related to the study of the intestinal microbiome will be emphasized. It is anticipated that this inaugural course on this topic will prompt a wide range of investigators to obtain training in techniques relevant to this field. Because microbiome studies are changing basic concepts of human biology so rapidly, and because so few trainees in this field are in the pipeline, it is critical that investigators learn about these emerging data, so that they can help convert this information into useful knowledge rapidly and efficiently, which is the goal of the course. [unreadable] [unreadable] [unreadable]

Public health relevance
Public Health Relevance: Microbiome-related research promises to illuminate processes and treatments for multiple high frequency, high impact problems, including obesity, inflammatory bowel diseases, and necrotizing enterocolitis, and asthma. By holding a course on this topic under the NIH conference mechanism, we will disseminate knowledge pertaining to this promising field of study. The course will be targeted to trainees and faculty across a broad set of disciplines, so as to prompt novel applications for many areas of human biology, thereby increasing and accelerating the public health impact of this work.